Ocular Immune Regulation by Mesenchymal Stem Cells

SUMMARY: This is a competitive renewal application to further define the immunoregulatory function of mesenchymal stem cells (MSCs) in ocular inflammation. Renowned for promoting tissue regeneration and immune quiescence, studies have demonstrated the therapeutic potential of MSCs in human disease. Nevertheless, fundamental questions remain unanswered regarding their immunomodulatory mechanisms. This proposal employs a well characterized transplant model of the murine cornea to systematically investigate how MSCs directly interact
with T cells to regulate alloimmunity. Over recent years the work of several laboratories, including our own,
has made substantial progress in understanding how MSCs regulate ocular inflammation. With respect to
corneal transplantation, we and others have shown that exogenous administration of MSCs suppresses
alloimmunity and promotes graft survival. Reports from our laboratory provide evidence that MSCs: (i)
specifically home to the ocular surface following corneal transplantation, where they act to (ii) limit antigen-presenting cell (APC) maturation, and (iii) decrease graft-destroying T helper-1 (Th1) cell responses.
Moreover, our preliminary data and reports indicate that the administration of MSCs following transplantation
induces Foxp3+regulatory T cells (Tregs). Despite these observations, the exact mechanisms by which MSCs
suppress generation and function of graft-attacking CD4+ T effectors and induce Foxp3+ Tregs are not known.
Our investigations indicate that, in addition to indirect modulation via APCs, MSCs exert a direct
immunomodulatory effect on both T effectors and Tregs.
We define 3 specific aims to answer the following questions: Aim 1: What are the mechanisms by
which MSCs inhibit generation of alloreactive Th1 cells? and Aim 2: How do MSCs promote the generation of
tolerance-inducing Tregs? Based on our robust preliminary and published data, we hypothesize that: (1) MSCs
inhibit downregulation of anti-proliferating factor, Tob1, in naïve T cells preventing their proliferation and
differentiation into Th1 cells; and (2) MSCs skew the differentiation of naïve T cells toward Foxp3+ Tregs via
CD80/CTLA-4 interaction. The principal objective of this project is to define the molecular mechanisms by
which MSCs directly interact with T cells to regulate alloimmunity. Given the considerable expense of
delivering MSC-based cell therapies, identifying the factors that mediate the immunoregulatory activity of
MSCs is a research priority. It is anticipated that the completion of these entirely novel aims will elucidate as-yet-unknown mechanisms by which MSCs regulate T cell responses, and may conceivably provide a
framework for the development of new therapeutic approaches in transplantation and other T cell-mediated
inflammatory disorders

Public health relevance
NARRATIVE: Mesenchymal stem cells (MSCs) have shown great promise in reducing inflammation and lowering graft rejection rates in corneal transplants. However, exactly how MSCs control immune responses remains unclear. This study aims to uncover these mechanisms, with the goal of developing new treatments that could benefit not only transplant patients but also those with various inflammatory and autoimmune diseases.